Topological Machine Learning to Characterize Higher-Order Brain Connectivity Alterations in Alzheimer's Disease

Current and upcoming clinical treatments for Alzheimer’s disease (AD) rely on early intervention during the prodromal
stage of mild cognitive impairment (MCI) to alter prognosis. In order to achieve this, noninvasive imaging
biomarkers are being developed to discern the progression of disease. One such class of biomarkers are networkbased
biomarkers, which detect topological alterations in structural and functional brain networks that are related
to disease stages and may additionally provide insight into the disease mechanism at a systems level. However,
literature on network-based biomarkers in AD has offered diverging and conflicting interpretations of brain network
topological alterations throughout the disease’s progression, leading to a significant barrier of progress in the
field. The discrepancies are attributed to differences in brain network construction methods across studies, such
as a priori network edge thresholding, which are not standardized and have a confounding impact on downstream
observations, and thus demonstrates a clear and present need for more robust methodology in network-based
analysis of neurodegenerative disease.
Our project addresses the issue by leveraging threshold-free topological data analysis (TDA), which promises
to be more robust than traditional graph theory for measuring topology by circumventing a priori thresholding.
Firstly, we will investigate the applicability of TDA-based statistical models, comparing properties of topological
profiles to observe robust brain network topological differences among cognitively normal (CN), MCI, and AD
subjects, and associating these topological properties with other diagnostic biomarkers. Secondly, we will use
novel machine learning methodology incorporating features derived from TDA in a classification paradigm, using
properties of brain network topology to predict diagnostic classes of CN, MCI, and AD. The project will further
establish the robust methodology of TDA in studying AD, as well as constructing novel network-based biomarkers
for early identification of the disease. In addition, this NRSA F31 proposal offers novel training opportunities
for the applicant in areas of applying advanced machine learning, artificial intelligence, statistical analysis, and
computational approaches for analyzing big biobank and neuroimaging data to advance the study of AD and
AD Related Dementia (ADRD), along with the training in professional development that will further prepare the
trainee for the next phase of his career as an independent researcher. A world-class mentoring team of sponsor
and co-sponsor will provide complementary advising and research resources as the NRSA predoctoral trainee
gains independence over the course of this project.

Public health relevance
Alzheimer’s disease (AD) is one of the most pressing health concerns that impacts over 55 million individuals globally and non-invasive imaging biomarkers are being developed to discern the progression of disease. This project aims to use innovative topological data analysis (TDA) and machine learning of functional and structural brain connectomes derived from neuroimaging data for AD diagnostic classification. The successful completion of this study will develop a novel set of non-invasive, network-based biomarkers for early detection and prediction of Alzheimer’s disease using new machine learning paradigms.